Investigating Citric Acid Cycle Perturbations in Complex I Deficient Mitochondrial Encephalopathy

ABSTRACT
Mitochondrial diseases are respiratory chain disorders in which the mitochondria are no longer operating
efficiently to produce ATP, usually due to a problem with one or more components of the oxidative
phosphorylation machinery. Mitochondrial diseases manifesting as encephalopathies occur at a rate of 1 in 5000
live births and are often fatal in the first few years of life. The genetic cause and clinical course of these
encephalopathies, e.g., Complex I deficient Leigh Syndrome, are well-described. The effective treatment of these
diseases is limited by our lack of mechanistic understanding of pathomechanisms that drive neuronal decline,
beyond the known Complex-I bioenergetic deficit.
We have previously described the reaction of the citric acid cycle metabolite fumarate with protein cysteine
residues to generate an irreversible modification, 2-succinocysteine (2SC), also known as protein succination.
Fumarate and protein succination increase in the Ndufs4 knockout mouse model of mitochondrial Complex I
deficiency. We demonstrate that the succination of a component of the α-ketoglutarate dehydrogenase (α-
KGDH) complex impairs the enzymatic activity of this complex. This results in decreased succinyl CoA production,
and impaired substrate level phosphorylation to produce much needed GTP/ATP. We hypothesize that metabolic
acidosis derived from the Complex I loss redirects α-KG toward 2-hydroxyglutarate production. We predict that
this influences the epigenetic landscape in the affected neurons.
The citric acid cycle of other non-neuronal cells are also impacted in the Ndufs4 knockout mouse. We show
preliminary data to demonstrate an impaired ability to produce itaconate, an important anti-inflammatory
metabolite. This is significant given the accumulation of microglia in the center of neuropathological lesions. Our
novel hypotheses link specific citric acid cycle perturbations to the chemical modifications of proteins that may
accelerate the biochemical damage within the regions most affected by pathology. To address these specific
pathomechanisms we outline targeted therapeutic approaches that should reduce the drivers of neuropathology.

Public health relevance
PROJECT NARRATIVE Mitochondrial diseases, including Leigh Syndrome, affect 1 in 5000 live births. These studies will determine if the bioenergetic deficit due to impaired mitochondrial Complex I function is exacerbated by defective function of the citric acid cycle. We will determine if alternative metabolite generation facilitates the neuropathological decline. We will also investigate site-specific therapeutic strategies that may be rapidly translatable for humans.